Core 001 - Virology Core

PROJECT SUMMARY
Core B Virology will serve as a centralized research resources to facilitate the research objectives of this P01
program. The functions of Core B include (1) collect and develop a library of HCV research reagents and
maintain their supply for the program; (2) perform standardized assays for quality-control of HCV antigens,
measurement of antibody titers and virus neutralizing activities, to ensure consistent and reproducibility of
experimental results; (3) processing animal samples for downstream experiments; (4) develop and document
standardized research reagents and assays to accelerate HCV vaccine development. Core B Virology will
improve cost efficiency, data quality and synergy of the research projects and cores of the P01 program.